Sleep disturbance and inhibitory control as proximal predictors of suicidal ideation and behavior: A daily diary and actigraphy study of young adults

Project Summary/Abstract
Suicide is the second leading cause of death among young adults aged 18-34 in the United States. There is an
urgent need to identify clinically-relevant behavioral factors that are predictive of suicide risk across diverse
populations, as well as to identify the mechanisms through which these factors confer risk. Disturbed sleep has
been identified as a proximal risk factor for suicide outcomes, including ideation and attempts. Importantly,
sleep is modifiable, making it a critical focus of research attention. The proposed study will utilize daily diary
and actigraphy methodologies over 21 days to examine the effects of sleep disturbance—a specific,
modifiable, immediately proximal risk factor for suicide outcomes in young adults—on next day suicidal
ideation and attempt behavior. In addition, we will examine inhibitory control as a time-varying mechanism
through which daily sleep disturbance may confer proximal risk for suicide outcomes. We will fulfill the aims of
RFA-MH-20-326 and NIH Strategic Objective 2.2 by investigating longitudinal relationships of the RDoC
domains of Arousal and Regulatory Systems (construct: sleep disturbance) and Cognitive Systems (construct:
inhibitory control) at multiple units of analysis (units: behavioral, self-report, paradigm) on a daily timescale
over a 21-day period. This study will be conducted with a transdiagnostic, economically disadvantaged, high-
risk sample of diverse young adults (ages 18-34), consistent with NIH’s call to identify biomarkers that predict
suicide outcomes across diverse populations.

Public health relevance
Project Narrative Suicide is a major public health problem among young adults, and there is an urgent need to identify clinically- relevant behavioral factors that are predictive of suicide risk across diverse populations, as well as to identify the mechanisms through which these factors confer risk. This study will utilize daily diary and actigraphy methodologies over 21 days to examine the effects of sleep disturbance—a specific, proximal, modifiable risk factor for suicide—on daily suicidal ideation and behavior, and examine inhibitory control as a time-varying mechanism for the relationship. Our focus on a racially and ethnically diverse and economically disadvantaged sample of young adults will further existing research and contribute to the identification of biomarkers that predict suicide outcomes across diverse populations.